SURVEY OF SERIOUS ADVERSE REACTIONS ASSOCIATED WITH ALLERGENIC PRODUCTS

Review of reports of fatalities with allergenic extracts submitted to FDA is ongoing. Post marketing survey of serious adverse reactions associated with licensed grass pollen extracts is under development.